Editing AMD Risk Alleles in Human Cells

ABSTRACT
Age-related macular degeneration (AMD) is a major cause of vision loss, affecting millions of individuals.
Two major loci (ARMS2/HTRA1 and CFH) drive most of the risk for AMD. The genes responsible for the
pathophysiology of these loci are expressed in ocular cells where they exert their effects.
New developments in genome editing have greatly increased the efficiency of editing and reduced the
likelihood of off-target events; and the application of these technologies (base editing and prime editing)
offers promise for the permanent reduction of risk, especially important as a means to slow or arrest disease
progression. Whereas existing treatments for exudative and atrophic AMD can be employed only following
neovascularization or geographic atrophy, genome editing to diminish AMD risk in eyes with high-risk
genotypes could be employed in a preventative manner. This grant application seeks to address the
technological and tissue-specific considerations for editing the pathogenic alleles in two AMD loci (10q26
harboring ARMS2/HTRA1, and 1q harboring CFH).
In this multicenter program with experts in retinal stem cell biology, AMD pathology, base editing and
prime editing, virus like particle packaging, and gene expression, we will conduct base editing and prime
editing of risk loci in human cells including iPSC-derived RPE, retina, and choroid, and donor retinal and
choroidal explant cultures.
Upon completion, this research program will address fundamental science questions regarding the impact
of ARMS2 A69S gene on HTRA1 expression and the role of CFH variants in complement deposition.
Additionally, it will shed light on translational science questions, exploring the efficacy of advanced gene
editing for modifying critical risk genes in AMD.

Public health relevance
NARRATIVE Age-related macular degeneration (AMD) is a major cause of visual disability. There are two major genetic risk factors that greatly influence one's chances of developing AMD. In this proposal, we will use novel methods developed by members of our team for converting (“editing”) high-risk genetic variants to their low-risk forms in human ocular cells and tissues (where the genes exert their effects) to address the potential of gene editing for preventing the onset or delaying the progression of AMD.